Administrative Core

Administrative Module - Project Summary
The Administrative Module provides the overall supervision and management of the University of Washington’s
Vision Research Core. This will be accomplished under the leadership of the PI, Maureen Neitz, PhD with
assistance from the Advisory Group consisting of the resource/service module directors. The Advisory Group
has two main functions. The first is to monitor the projects of the core component scientific personnel, to
provide direction and coordination with respect to the projects, and to identify opportunities for collaboration
among UW vision researchers. The second is to oversee management of the core grant. Support staff is
provided through the Administrative Module for managing budgets, scheduling events, and preparing reports.
The Administrative Module provides a mechanism for dispute resolution.